Minnesota Veterinary Drug Residue Prevention Program

Project Abstract The Food and Drug Administration (FDA) is announcing the availability of cooperative agreements (RFA-FD-16-021) to State government animal derived food prevention programs. The intent of these agreements is to fund training and outreach programs for individuals and parties involved with medicating animals intended for food, including support of education and outreach activities related to extralabel drug use requirements and other prevention activities. The Minnesota Department of Agriculture (MDA) has regulatory oversight for animal feed, dairy, meat and egg products. As such, the MDA has extensive opportunity to conduct outreach and educational activities focused on veterinary drug residue prevention and extralabel drug use regulations. In addition, the MDA has subject-matter expertise in terms of veterinary leadership and technical skills in veterinary drug use and extralabel requirements, as well as experience in residue investigation and response through its extensive participation in tissue residue and milk residue investigations. As a part of this application, the MDA intends to develop and implement a Minnesota drug residue prevention program that includes creation and enhancement of outreach materials, conducting outreach and educational events and the development and maintenance of a scalable web-based training module. The funding requested for this project would provide a basis for short-term activities and result in a plan for continuing activities with industry and related organizations as partners.

Public health relevance
Project Narrative The Minnesota Department of Agriculture (MDA) seeks to develop and implement a Minnesota drug residue prevention program in cooperation with the Food and Drug Administration. The purpose of this program is to create and implement a residue prevention program that addresses appropriate and legal extralabel drug use for veterinary drugs, best practices for veterinary drug residue prevention in animal derived food products, and other related outreach activities. The main objectives of this project are to reduce veterinary drug residues in animal food products and to improve awareness and the knowledge about extralabel drug use requirements for people who handle veterinary drugs and treat food producing animals with these drugs. By reducing residues and improving veterinary drug stewardship practices, the project's efforts can improve public health by increasing the safety of the food supply, specifically products that come from animal agriculture. This project would generate educational and outreach resources that would be able to be used by FDA, other State agencies, and other organizations that provide education and outreach to livestock producers, students, and veterinarians. The roadmap and foundation for this project can be, and will be available, to be used to continue efforts at residue prevention in Minnesota in conjunction with other associations and trade organizations into the future.